Single-cell resolution analysis of chromatin accessibility and gene expression changes in a model of drug addiction

!
Project Summary
Every year, more than 100 Americans a day die after overdosing on opiates. Addiction to opioids, including
prescription drug such as oxycodone, and illicit drugs such a s heroin and fentanyl, is a national crisis that
affects public health and the economy. Thus, there is an urgent need to develop better treatments for opiate
addiction, which requires a better understanding of its biological basis. The primary goal of our proposal is to
identify cell types and cell type-specific gene expression patterns associated with higher vulnerability to
compulsive oxycodone use in an unbiased and quantitative way. We will accomplish this goal by implementing
single-cell sequencing assays to measure gene expression and chromatin accessibility in thousands of
individual cells in a single experiment. We will use brains of N/NIH heterogeneous stock (HS) rats that have
undergone the extended access to oxycodone self-administration procedure. We focus on HS rats because
they are genetically diverse and exhibit an exceptional behavioral repertoire. These rats are characterized as
vulnerable or resistant to oxycodone compulsive intake based on advanced analysis of addiction-like
behavioral traits, including tolerance, dependence, motivation, and compulsive drug intake. This behavioral
paradigm recapitulates many of the key neuroadaptations observed in human addiction and has high face,
predictive, and construct validity for oxycodone use disorders. This project takes advantage of a brain tissue
repository of HS rats that have been genotyped and characterized as vulnerable and resistant to compulsive
oxycodone use. The oxycodone biobank (www.OxycodoneBioBank.org) will provide the samples to be used in
this project. We will focus on the nucleus accumbens, a brain region involved in the transition from moderate to
excessive drug use. Our preliminary studies on single-cell analysis of the cerebral cortex provide a compelling
strategy to study the biological basis of opiate addiction. We propose: 1) to use single-cell RNA-seq to identify
gene expression changes in brains of HS rats that are characterized as prone or resistant to oxycodone
compulsive use (Specific Aim 1); 2) to use single-cell ATAC-seq to identify changes in chromatin accessibility
and transcription factors binding sites in the same population of HS rats (Specific Aim 2); 3) to use H3K27Ac-
PLAC-seq to link distal regulatory elements to target genes involved in oxycodone addiction-related behaviors
(Specific Aim 3). This project will benefit from multiple expertise and will leverage existing resources, including
those provided by the oxycodone biobank (U01DA044451) and the NIDA center for GWAS in outbred rats
(P50DA037844). We believe that the proposed studies have the potential to lead to groundbreaking
discoveries in the mechanistic bases of opioids addiction. The integrative analysis of our sequencing datasets
will provide considerable new insights concerning the contribution of distinct cell-types to molecular changes
associated with addiction related phenotypes.
!
!

Public health relevance
Project Narrative Despite intensive efforts to understand the molecular mechanism underlying the neuroadaptations associated with addiction phenotypes, current knowledge can only partially explain which cell type orchestrates specific transcriptional responses to addictive drugs in the brain. By systematically analyzing the cell-type specific transcriptional and chromatin accessibility changes that occur in brain regions of rat with different history of oxycodone use, this application aims to provide unprecedented insights in the biological basis of opiate addiction. This project focuses on the emerging and complex problem of prescription pain relievers and opioids abuse in this country.